Genetics and genomic research in Uganda: Towards context specific ethics guidelines

PROJECT SUMMARY/ABSTRACT (ORIGINAL PROPOSAL)
This supplement is submitted to request an extension of the project Genetics and genomics
research in Uganda: Towards context-specific ethics guidelines U01HG009822 until June 30,
2023. The overall goal of this proposed project is to systematically develop culturally appropriate
model ethics guidelines for conducting genetics and genomics research (GGR) in Uganda. This
goal will be achieved through the following specific aims:1) to assess stakeholder awareness of
GGR, and the nature of ethical and social concerns associated with GGR in Uganda, to better
understand local needs and issues and provide robust data for later guideline development; 2) to
evaluate existing guidelines on the ethics and oversight of GGR for applicability to the Ugandan
setting with a particular emphasis on guidelines developed by and for Africa, and; 3) to develop
and disseminate a model guideline for the ethics of GGR in Uganda. GGR has been conducted
in Uganda for more than 20 years, and the volume of GGR activity is expected to continue to
increase because of its potential to advance targeted disease detection and interventions to
address significant burdens of communicable and non-communicable disease in the country.
Ethical, legal and social challenges that accompany such research – such as complexities
involving informed consent; data ownership, access and use; risk mitigation; and subject selection
– are the focus of increasing discussion and concern in Uganda and other countries in sub-
Saharan Africa. Indeed, scholars of the H3Africa consortium have developed a detailed ethics
framework for GGR in Africa that begins to account for many of these issues. Building on this
important work, as well as ongoing and completed H3Africa projects in Uganda (UH2 HG007051-
01A1 and UH2 HG007051-01A1), we propose a project that is directly responsive to demands
from within Uganda, to move towards the development of country-specific guidelines that are
capable of being adopted by local regulatory authorities and that reflect the unique social, legal
and cultural context of Uganda. The proposed project brings together an inter-disciplinary team
of experts with a long history of research collaboration, experience in research ethics, and
expertise in national and international guideline development to advance knowledge and
oversight of GGR in Uganda. The proposed four-year project will conduct robust, mixed-methods
research to generate information that will contribute not only to collective understandings of the
ethical challenges facing GGR in Africa, but also to the evidence base needed to develop
culturally appropriate ethical guidelines for conducting GGR in Uganda. Indeed, the project will
culminate with the development and dissemination to national regulatory authorities, of a model
guideline for GGR in Uganda In doing so, we bring together a team of Ugandan and international
bioethicists, social scientists, clinicians, genomics researchers, public health professionals and
research oversight experts to contribute to the advancement of knowledge and practice of GGR.
PROJECT SUMMARY (SUPPLEMENTARY PROPOSAL)
This supplement is submitted to request an extension of the project Genetics and genomics
research in Uganda: Towards context-specific ethics guidelines U01HG009822 until June 30,
2023. The overall goal of this proposed supplementary project is to is to increase awareness and
uptake of the ethical guidelines for the conduct of genetics and genomics research in Uganda.
This goal will be achieved through dissemination of the developed GGR ethical guidelines using
a rigorous process to attain comprehensive and meaningful stakeholder engagement of key
stakeholders including REC members and research teams. REC members who use guidelines
for ethical review and oversight as well as GGR researchers will be engaged to facilitate
awareness and uptake of the guidelines.

Public health relevance
PROJECT NARRATIVE This supplement is submitted to request an extension of the project Genetics and genomics research in Uganda: Towards context-specific ethics guidelines U01HG009822 until June 30, 2023. Awareness and uptake of guidelines for ethical conduct of research can be a slow process and requires a good will from stakeholders. Effective engagement is expected to facilitate the understanding, appreciation and use of the ethical guidelines for conduct of genetics and genomics research in Uganda by researchers and research regulators. Through an interdisciplinary collaboration of Ugandan and international experts in bioethics, law, social science, philosophy, genetics and genomics research, and clinical science we propose to undertake a rigorous process of stakeholder engagement to facilitate awareness and uptake of the guidelines for ethical conduct of genetics and genomics research in Uganda.